Cancer Treatment Disparities in the HIV Population: Exploring the Impact of HIV on Physician and Patient Decision-Making

PROJECT ABSTRACT
The overall goal of this NCI K08 proposal is to facilitate Dr. Gita Suneja's development into an independent
investigator focused on improving cancer treatment rates and outcomes among HIV-infected cancer patients.
Cancer is now the leading cause of non-AIDS death in the HIV population. Cancer survival is significantly
worse in people living with HIV compared with the general population, in part because they frequently do not
receive appropriate cancer treatment. Dr. Suneja's prior work revealed that oncologists are less likely to offer
cancer treatment to HIV-infected patients; however, empiric data on how the diagnosis of HIV affects cancer
treatment decision-making by physicians and patients is lacking. The research objectives of this application are
to (1) develop a comprehensive understanding of the decision-making process, (2) evaluate the impact of HIV
on cancer treatment decision-making, and (3) design a decision support tool for oncologists to promote
evidence-based cancer treatment and shared decision-making with HIV-infected patients. The long-term goal
is to reduce cancer treatment disparities in the HIV population. To achieve these goals, Dr. Suneja will
capitalize on the resources available at Duke University, where she is a faculty member in the Department of
Radiation Oncology. Her career development plan incorporates training in mixed methods research, decision-
making science, and intervention design - nested within a structured environment of strong multidisciplinary
mentorship - that will uniquely position her for an academic career in cancer health services research.
In Aim 1 of the proposed study, the investigators will directly observe oncologist-patient interactions to
generate a unique and detailed understanding of the cancer treatment decision-making process and the impact
of HIV on treatment decision-making. In Aim 2, they will survey a national sample of oncologists identified from
the population-based HIV/AIDS Cancer Match Study to systematically identify determinants of cancer
treatment decision-making and solicit input on parameters for a clinical decision support tool. Together, data
from Aims 1 and 2 will produce detailed and generalizable knowledge on the key elements of the decision-
making process that are appropriate intervention targets. In Aim 3, the investigators will utilize a User-Centered
Participatory Design framework to develop a clinical decision support tool for oncologists to promote the
delivery of evidence-based, patient-centered cancer care to HIV-infected patients. This study will fill a critical
void in our understanding of cancer treatment disparities in a population living longer due to effective
antiretroviral therapy. In addition, the career development award will provide Dr. Suneja with the analytic
training and research deliverables necessary to compete for an R01 award to measure the real world impact of
the intervention on cancer treatment rates in the HIV population.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it addresses the cancer treatment disparity in HIV-infected individuals by generating actionable research to improve the provision of cancer care to this vulnerable population. “Research to Reduce Health Disparities” has been designated a high priority area in the NIH HIV/AIDS Research Priorities and Guidelines for Determining AIDS Funding (NOT-OD-15-137). This research proposal directly addresses this priority and represents an important first step towards ensuring equitable cancer treatment for HIV-infected individuals.